Exploiting somatotopy within the cervical vagus in a chronic large animal model

Abstract Summary
Vagus Nerve Somatotopy using the COSMIIC System
In this Supplement, we will use the COSMIIC Platform System components to assess the
impact of chronic fibrous encapsulation on evoked recording from the cervical vagus nerve
immediately post-implant and chronically over time. Recent studies have provided basic proof
of concept that smaller, multi-contact electrodes may stimulate specific portions of the cervical
vagus to selectively activate intended therapeutic pathways while minimizing co-activation of
off-target pathways. These studies were performed acutely under anesthesia. In this
supplement, we intend to leverage the HORNET system for chronic stimulation and recording to
develop pilot data to address these gaps. The aims of this supplement are: 1) assess the impact
of chronic fibrous encapsulation on evoked emg, eng, and physiological responses over time
with continuous stimulation started immediately post-implant, and 2) assess the impact of
chronic continuous stimulation started 1-month post-implant on evoked emg, eng, and
physiological responses over time.

Public health relevance
Project Narrative Vagus Nerve Somatotopy using the COSMIIC System In this Supplement, we will use the COSMIIC Platform System components to assess the impact of chronic fibrous encapsulation on evoked recording from the cervical vagus nerve immediately post-implant and chronically over time.